Diacylglycerol kinase regulation of airway smooth muscle functions

Project Summary
Gq family G protein-coupled receptors (GPCR) and receptor tyrosine kinases (RTKs) on airway smooth
muscle (ASM) and T cell receptors (TCR) on T cells are critical in orchestrating cellular responses leading to
airway hyperresponsiveness (AHR), remodeling and inflammation in asthma. Activation of these receptors
leads to the generation of diacylglycerol (DAG) and inositol 1,4,5-triphosphate (IP3) by the action of
phospholipase C. DAG, working in synergy with IP3-Ca2+ signaling and directly activating PKC and Ras guanyl
nucleotide-releasing protein, promote ASM contraction and proliferation. However, the independent role of
DAG in ASM functions remains less explored. DAG is phosphorylated and further converted into phosphatidic
acid (PA) by enzymes known as DAG kinases (DGK). Our studies demonstrated that pharmacological and
genetic inhibition of DGK inhibits ASM cell contraction and proliferation and attenuates the development of
allergen-induced airway inflammation, features of airway remodeling, and AHR in mice. The functional effects
of DGK inhibition are counter-intuitive as DGK inhibition is expected to enhance DAG-mediated signaling and
promote ASM contraction and proliferation. The functional dichotomy of DGK inhibition suggests a complex
relationship between phospholipid second messengers and the enzymes responsible for their synthesis (PLC)
and degradation (DGK). Indeed, the preliminary data presented in this application suggest that low-level and
transient elevation of DAG negatively regulates Gq-PLC activity. In this proposal, we aim to uncover the
molecular mechanisms by which DGK regulates ASM contraction and proliferation and T cell-mediated
immune response. Our central hypothesis posits that DGK isoforms serve as pivotal regulatory checkpoints
and fine-tune the spatiotemporal phospholipid signaling in ASM cells. Further, the inhibition of DGK perturbs
this delicate equilibrium and attenuates the asthmatic airway response by affecting the stoichiometry of lipid
second messengers responsible for ASM functions. To achieve our goals, we will employ diverse, state-of-the-
art tools such as targeted phosphoproteomics, lipidomics, fluorescence sensors and genetic/pharmacological
inhibition of DGK. In Aim 1 studies, we will discern how DGK inhibition impacts phospholipid signaling and the
activation of effectors involved in ASM contraction. In Aim 2, our studies will focus on establishing how DGK
isoforms regulate DAG kinetics and signaling, which in turn regulate ASM cell proliferation. Finally, to establish
the therapeutic relevance of our findings, Aim 3 studies will test the efficacy of a newly developed DGKζ
isoform-specific small molecule inhibitor (ASP1570) in mitigating features of allergic asthma in a murine model.
We will also discern the mechanism by which DGKζ inhibition modulates T cell-mediated immune response.
Collectively, our studies will provide a deeper understanding of the intricate regulation of phospholipid signaling
and functions in ASM and T cells. Furthermore, they will demonstrate the efficacy of inhibiting the ζ isoform of
DGK in mitigating multiple features of asthma.